A Scalable Video-Coaching Intervention for Opioid-Using Mothers

7. PROJECT SUMMARY/ABSTRACT
Over 2 million Americans have opioid use disorders, and millions more misuse opioids. In communities
severely affected by the opioid crisis, as many as 10% of newborns are affected by neonatal opioid withdrawal
syndrome, which costs upwards of $1.5 billion annually. A large body of research documents the many
negative consequences of being raised by a mother with opioid addiction, especially in infancy and early
childhood. In addition, many mothers find that having a child is a strong motivation to seek treatment for their
opioid use and/or addiction. For these mothers, there are currently no evidence-based parenting interventions
to support them. Moreover, very little is known about mediators and moderators of the effectiveness of early
childhood parenting interventions more generally (i.e., what works for whom and why), which limits the ability
for researchers to identify how the systems targeted by these programs may be affected by opioid use. The
overall objective of the proposed study is to conduct a randomized efficacy trial with a diverse sample of low-
income families with children ages 0–36 months whose mothers are in or have been referred to treatment for
opioid use and/or addiction. We will work with our Advisory Board and our community partners to adapt the
evidence-based, scalable, Filming Interactions to Nurture Development (FIND) program to this treatment
context (Aim 1), and then use a longitudinal randomized efficacy trial to test the central hypothesis that
associations between increases in responsive caregiving (the main FIND target), and subsequent caregiver
well-being and child developmental and biobehavioral outcomes (secondary targets), will be partially mediated
through changes in caregiver inhibitory control (measured behaviorally and with neuroimaging methods) and
parent self-concept (Aims 2-3). The rationale for this work is that it simultaneously addresses the unmet needs
of a vulnerable, significantly underserved early childhood population and allows for a rigorous test of our
conceptual model. We will randomize 200 primary caregivers and their 0- to 3-year-old children to receive
FIND or an active control intervention (all participants will receive addiction treatment from their referral
source). Aim 2 quantifies the main effects of FIND on changes in responsive parenting and related caregiver
and child outcomes immediately after the intervention, and the durability of these effects 6 months later. Aim 3
explores underlying neural mechanisms that mediate associations between FIND-related changes in caregiver
behavior and caregiver/child outcomes and the specificity of those mechanisms, and assesses the degree to
which these associations are moderated by neonatal opioid withdrawal or abstinence syndrome. Within-group
analyses will also examine intervention fidelity and dosage. This information is critical to addressing differential
response to early childhood interventions for children ages 0–3, to increase impact and scalability. These
outcomes will have a positive impact in that there are currently no evidence-based, early childhood parenting
interventions designed to be implemented in a treatment setting. An easily delivered program that can be
provided while these parents seek treatment for opioid misuse may facilitate their children's development and
reduce risks.